UJMT – Morehouse School of Medicine Supplement

ABSTRACT
The UJMT Fogarty LAUNCH Program has an established track record in global health research, supporting over
270 US and international trainees to date. While the program has sought to recruit individuals from diverse
backgrounds, to date the applicant pool has been limited and poorly defined. Traditional metrics such as race
and ethnicity alone have been inadequate and fail to capture the richness and potential of diverse perspectives
in global health. The Fogarty Pathway Program at the Morehouse School of Medicine has been designed to
address this gap. Built upon past programmatic experiences and formative research, this newly proposed
initiative seeks to orient and train 10 doctoral students (medical or PhD) through didactic and experiential
learning. The program focuses on global hemoglobinopathies research, a scientific priority for NIH and an area
of ongoing work for participating US and international faculty. The format is a four-week course abroad, where
US students are taught and supervised in a fostering, mentored environment. Opportunities will be available
through separate trips to Accra, Ghana and Kingston, Jamaica. Although the core curriculum will be similar, each
builds upon existing relationships and ongoing projects at NIH-approved institutional partners. Recruitment will
focus on individuals who are interested in global health but lack the formative experiences needed to spark
further career growth. It will emphasize diverse backgrounds, which will be broadly defined in a manner that is
nuanced, inclusive, and fully aligned with the program announcement. In this pilot phase, the Fogarty Pathway
Program will be rigorously evaluated for content, delivery, and participant outcomes. This initiative will enrich the
pool of diverse applicants to the UJMT Fogarty LAUNCH Program in ways that remain distinct yet complementary
from the parent award. With a demonstration of feasibility and early impact, this initial investment will lead to
sustainable institutional and/or funder support of this important global health pathway.

Public health relevance
NARRATIVE The proposed Fogarty Pathway Program is an intensive, four-week curriculum designed to train US doctoral students from the Morehouse School of Medicine. Developed with institutional partners from Ghana and Jamaica, this pathway initiative will recruit individuals from diverse backgrounds and provide mentorship and individualized support to catalyze careers in global health research.